Macrophage Phenotypes and Tissue Repair

Project Summary
The overall goals of my laboratory over the next 5 years are to better understand the
heterogeneity of inflammatory cell function over the course wound healing, focusing on
monocytes, macrophages and Natural Killer cells. We plan to address three focus areas using
models of normal (non-diabetic), impaired (diabetic) and improved (LIV-treated diabetic) skin
wound healing: First, we will elucidate mechanisms that enable inflammatory cell
proliferation after entry into the wound. We will identify mechanisms underlying transitions of
monocytes from a proliferative state in bone marrow, to a non-proliferative state in blood, and
then back to a proliferative state in damaged tissue. We will also investigate mechanisms that
regulate Natural Killer cell proliferation in wounds. Second, we will elucidate the role of
infiltrating versus resident inflammatory cells in wound healing. We will use lineage tracing
techniques to determine roles of infiltrating versus resident macrophages and Natural Killer
cells in wound healing. Third, we will elucidate inflammatory cell communication pathways
with other wound cells. We will use spatial transcriptomics to refine our current models of
monocyte, macrophage and Natural Killer cell communication with other wound cells over space
and time and will perform mechanistic testing of these models. To address each of these focus
areas, we will use scRNAseq, scATACseq, spatial transcriptomics and downstream analysis to
identify pathways involved in the regulation of inflammatory cell heterogeneity These studies will
guide mechanistic experiments using available blocking antibodies, transgenic mice and bone
marrow transfer. For the most promising candidates, cell-specific transgenic mice will be
generated. To determine the degree to which our mouse data relates to human wound healing,
we will map our results to published human wound scRNAseq and spatial transcriptomics
datasets. The overall vision of our approach is that by identifying novel regulators of monocyte,
macrophage and Natural Killer cell function during wound healing, we can develop novel
approaches to manipulate inflammation and improve healing of difficult wounds, and in the
process, generate a pipeline of candidate therapies to translate into clinical studies.

Public health relevance
Project Narrative Wound healing is critical to the survival of all living organisms and inflammatory cells play essential roles in the healing of all tissues. The goals of my laboratory over the next 5 years are to better understand the heterogeneity of inflammatory cell function over the course wound healing, and to elucidate regulatory pathways involved. We will focus on mechanisms that enable inflammatory cell proliferation after entry into the wound, the role of infiltrating versus resident inflammatory cells in healing, and communication pathways of inflammatory cell subsets with other wound cells. The overall vision guiding our approach is that by identifying novel regulators of inflammatory cell function during wound healing, we can develop novel approaches to manipulate inflammation and improve healing of difficult wounds, and in the process, generate a pipeline of candidate therapies to translate into clinical studies.